Comparative neurobehavioral pharmacology of combusted and non-combusted tobacco products

SUMMARY
The purpose of this project is to identify mechanisms mediating the differential abuse liability of combusted
cigarettes versus non-combusted tobacco products. Conventional tobacco cigarettes have greater abuse
liability than non-combusted products such as electronic cigarettes (ECs), smokeless tobacco, and nicotine
replacement therapy (NRT). To date, data from animal studies of exposure to extracts of commercial tobacco
products that contain nicotine and a range of non-nicotine tobacco constituents appear to be consistent with
the greater abuse liability of combusted products observed in humans. The mechanisms mediating the greater
abuse liability of combusted products remain unclear, but may reflect the unique or higher levels of addiction-
relevant non-nicotine constituents in cigarette smoke (CS). Some of these constituents (e.g., volatile organic
compounds, monoamine oxidase (MAO) inhibitors) can mimic or enhance the effects of nicotine, or can exhibit
abuse liability themselves. This project will compare the addiction-related behavioral and neurobiological
effects of CS extract, EC aerosol extract, and nicotine alone (NRT analog). Importantly, CS extract will contain
both water- and non-water-soluble constituents from both the particulate and gas phase of CS, thereby
providing the most comprehensive CS extract ever used in preclinical addiction studies. Levels of a range of
behaviorally relevant non-nicotine constituents in the extracts will be measured to identify specific constituents
that may be responsible for observed differences in abuse liability. Our general hypothesis is that CS extract
will have greater addiction-related behavioral and neurobiological effects than the other formulations due to its
higher levels of behaviorally active non-nicotine constituents. Aim 1 will compare the addiction-related
neurobiological and pharmacokinetic effects of CS extract, EC extract and nicotine alone, including binding
affinity and functional activity at a wide range of addiction-related receptors in vitro, ability to up-regulate
nicotinic acetylcholine receptors, produce MAO inhibition, and induce c-fos expression in addiction-related
brain areas ex vivo, ability to elicit dopamine and serotonin release in the nucleus accumbens in vivo, and
nicotine pharmacokinetics. Aim 2 will compare the reinforcement-enhancing and aversive effects of
formulations using intracranial self-stimulation, as well as their effects on ex vivo neural measures under these
dosing conditions. Aim 3 will compare the relative elasticity of demand for (reinforcing efficacy of) formulations
using self-administration methods when each formulation is available in isolation and under novel choice
procedures where each extract is available concurrently with nicotine to examine substitutability. This project
will provide the first direct comparison of both the addiction-related behavioral and neurobiological effects of
different classes of tobacco products, and will significantly advance our understanding of the basic
neurobiological mechanisms underlying the differential abuse liability between them. As such, this work may
inform development of better medications for tobacco addiction by tailoring them to different product classes.

Public health relevance
PROJECT NARRATIVE Although nicotine is the main addictive chemical in tobacco products, other chemicals in these products may also contribute to tobacco use. This study will examine whether the greater abuse liability of cigarettes compared to non-combusted products (for example, electronic cigarettes) reflects the presence of other chemicals in cigarette smoke and their neurobiological effects. These studies will help understand how chemicals other than nicotine contribute to tobacco addiction and might suggest ways to tailor medications to treat addiction to different classes of tobacco products.